Identification of Neural Markers of Aggression and Irritability and Their Capacity to Predict Treatment Response to CNS Stimulant Medication in Youth with ADHD

Abstract
Impulsive aggression and chronic irritability (IACI) often occur together and are some of the most common
reasons why children present for behavioral health (BH) care. ADHD is frequently associated with IACI as
upwards of 50% of youth with ADHD manifest impairing levels of it. IACI is the most common reason that
children with ADHD are prescribed antipsychotics and admitted to inpatient BH units. Systematic dose
optimization of CNS stimulants improves levels of IACI, reducing the need for these more intensive and
burdensome treatments. However, response varies, with over half of children with ADHD showing meaningful
improvement, upwards of 40% receiving minimal benefit and 3 to 10% exhibiting increased IACI levels.
Phenotypic and demographic variables are of limited utility for predicting response, suggesting the need to
move beyond symptoms in the search for treatment predictors. Youth with ADHD and IACI struggle with
multiple aspects reinforcement learning (RL), defined as learning from interactions with the environment to
reach a goal. Successful RL efforts tap multiple cognitive functions. In controlled laboratory tasks, youth with
IACI and ADHD exhibit abnormal behavioral and neural response to reward (reward responsiveness), difficulty
processing environmental cues to adapt behavior (set shifting/goal updating) and impaired attentional
allocation when blocked from a goal (frustrative nonreward). Event-related potentials (ERP) exist for each of
these research domain criteria (RDOC) that serve as established neural measures offering a child friendly
means to assess their contribution to observable levels of IACI. CNS stimulants improve functioning in these
specific realms and impact these associated ERPs to the degree that differences between ADHD and non-
ADHD youth disappear. In response to NIMH’s Notice of Special Interest on aggression (NOT-MH-22-095), we
will examine the capacity of these ERPs to predict levels of IACI in naturalistic settings. We will then assess if
interindividual variance in the capacity of CNS stimulants to impact RL associated ERPs accounts for
differences in the clinical effects of these medications on IACI at home using a multimethod battery integrating
ERPs, guardian report and task performance. Specifically, we will examine variance in the reward positivity
(RewP) ERP when receiving reward feedback, the switch positivity (SwP) ERP measuring mental effort when
cued to shift set and the change in P3b amplitude measuring attention allocation when transitioning from
reward to nonreward on a go-no-go task. To achieve these aims, 136 children with ADHD and elevated IACI
will have their CNS stimulant dose optimized over six weeks and then complete a two week within subjects
crossover trial of placebo versus optimal dose. ERP collection will be completed within each blinded week.
Guardian ratings will be gathered 3x per day including during peak and off-peak times of medication effect to
capture variance in IACI levels within the day and disentangle reports of worsening IACI related to loss of
previously beneficial medication effects versus those most likely due to a direct adverse response to drug.

Public health relevance
Project Narrative Impulsive aggression and chronic irritability (IACI) are some of the most frequent reasons children are referred for specialty behavioral health care, and ADHD is one of the most common pediatric conditions associated with impairing IACI. Central Nervous System (CNS) stimulants are a first line treatment for ADHD and have been found to improve IACI in youth with ADHD, but responses vary with 50 to 60% showing improvement, 30 to 40% showing little change and up to 10% displaying worsening IACI. There are currently no clinically useful markers to predict response to CNS stimulants in a specific child, so this study proposes to examine the association between the capacity of these medications to improve reinforcement learning as measured by EEG with the level of medication induced changes in IACI observed in children with ADHD.